Impact of Repeated Influenza Vaccination on Incidence of Influenza Illness

To investigate the relative protection of active duty military personnel, their dependents and retirees against influenza infection related to influenza vaccine experience.